GLYCOSYLATED RECOMBINANT HUMAN INTERLEUKIN-6 IN PATIENTS WITH SOLID TUMORS

This project will evaluate the safety and efficacy of the medication recombinant human interleukin in patients with solid tumors undergoing intensive antitumor therapy with chemotherapy.